SynchronyGamma: A Music-Based Intervention for Alzheimer's and Mild Cognitive Impairment

Project Summary/Abstract
In this proposal, Oscilloscape, LLC seeks NIH-SBIR funding to conduct usability and feasibility
studies on an innovative music-based digital health device that delivers non-invasive music and
Gamma (30-80 Hz) brain stimulation to help aging adults with Alzheimer’s Disease (AD) and
Mild Cognitive Impairment (MCI). The digital health device, herein referred to as
“SynchronyGamma,” is based on patented neural network technology that models the dynamics
of rhythmic brain activity. We previously used this neural network technology to develop a
scalable, low-cost LED-light controller, called Synchrony™, that creates colorful lighting effects
that synchronize to the beat of music. Synchrony™ is currently marketed for music lighting, but
its core algorithm has clinical potential, because it aims to stimulate healthy brain rhythms via
the process of neural entrainment. In clinical populations who have disruptions in brain rhythms,
e.g., patients with AD & MCI, we hypothesize that this technology can effectively restore normal
brain activity important for learning, memory, and cognition. Key outcomes of this project are
IRB-approved studies that 1) assess the usability of SynchronyGamma in independent living
facilities, and 2) assess the feasibility of SynchronyGamma as a brain stimulation tool by
studying the effects of SynchronyGamma on brain activity and cognitive abilities in a longitudinal
intervention in older adults with MCI or AD.
SynchronyGamma has potential to help age-related cognitive impairments by creating a
music-based, digital health device that delivers Gamma stimulation via music and lights.
Neurodegenerative disorders are a rapidly growing public-health concern, with AD alone
projected to affect 13.8 million Americans in 2050. AD patients undergo gradual cognitive
decline, with MCI being an early stage of the disorder. During this progression, patients
experience multiple pain-points, including memory loss, executive function deficits, and
depression. Early intervention in the MCI stage may reduce or even reverse cognitive decline.
While pharmacological interventions for AD have primarily targeted biomarkers such as beta-
amyloid (Aβ) plaques, these strategies have shown limited success in improving clinical
outcomes. Thus, there is an urgent clinical need to develop novel therapies for AD and MCI.
Recent findings that relate Gamma neural entrainment to Aβ offer an exciting avenue towards
non-invasive sensory interventions. Our objective is to validate SynchronyGamma as an
effective music-based therapy for restoring depleted brain activity, thus preserving and
improving memory and cognition in patients with AD and MCI.

Public health relevance
Project Narrative Oscilloscape, LLC and Northeastern University propose to conduct usability and feasibility studies on an innovative digital health device, called SynchronyGamma, to treat aging adults with Mild Cognitive Impairment (MCI) and Alzheimer’s disease (AD) using music and Gamma stimulation. Successfully developing SynchronyGamma would lead to an innovative, effective, low-cost, scalable, non-invasive digital health device for AD and MCI that capitalizes on intrinsically strong brain responses to music and employs cutting-edge research on brain stimulation for treating AD.